Mechanisms of Hippo signaling in Alcoholic liver disease

Alcoholic liver disease (ALD), a major cause of morbidity and mortality worldwide, includes a broad spectrum of disorders, ranging from simple steatosis to severe forms of liver injury such as steatohepatitis, alcoholic hepatitis, cirrhosis, liver failure and hepatocellular carcinoma. Aside from the direct cytotoxic and the oxidative- stress?mediated effects that alcohol and its metabolites exert on hepatocytes, alcohol ingestion also activates both the innate and adaptive immune responses in the liver, and dysregulates several important signaling pathways in the liver, thereby contributing to the pathogenesis of ALD. Recent studies suggest that impaired liver regeneration and inflammation are two important mechanisms contributing to liver failure in patients with alcoholic hepatitis. However, the underlying mechanisms remain unclear. The Hippo (Hpo) signaling pathway has recently emerged as a critical one regulating hepatocyte proliferation, survival as well as inflammation. Central to the Hpo pathway is the control of Yap/Taz transcription factors by a kinase cascade starting from the Hpo kinase, which are Mst1 and Mst2 in mammals. As hepatocyte injury is a major driving force for ALD pathogenesis, the goal of this explorative R21 proposal is to determine whether alcohol attenuates liver regeneration and induces liver inflammation by dysregulating the Hpo signaling pathway in hepatocytes. Despite the critical functions of Hpo signaling in restricting hepatocyte proliferation and survival we and others have identified, the precise functions and molecular mechanisms whereby the Hpo signaling pathway participates in alcohol-induced liver injury, inflammation and regeneration are mostly unknown. Hence, there are many unanswered fundamental questions regarding Hpo signaling in ALD. The knowledge gained from the proposed studies will establish a solid new foundation for further mechanistic investigation of Hpo signaling in ALD and provide new targets and strategies to protect liver from alcohol induced injury. Our unpublished preliminary data show that in a short-term chronic-binge ALD (E1d-1B) model, Mst1, Mst2 and Yap protein levels were reduced. We have also found that, infiltrated macrophage numbers and expression of pro- inflammatory cytokines are increased in the hepatocyte-specific Mst1 and Mst2 double mutant (DKO) liver. We hypothesize that reduction in Yap expression leads to increased hepatocyte cell death and impaired hepatocyte regeneration; while Mst1 and Mst2 down-regulation in hepatocytes of the alcoholic liver contributes to chronic pro-injury liver inflammation. In Specific Aim 1, we will define the effects of alcohol consumption on the Hpo signaling pathway in hepatocytes. In Specific Aim 2, we will determine whether alcohol feeding inhibits liver regeneration by reducing Yap in hepatocytes. In Specific Aim 3, we will determine whether alcohol feeding causes liver inflammation by reducing Mst1 and Mst2 in hepatocytes.

Public health relevance
In this project the investigators will determine how alcohol consumption attenuates liver regeneration and induces liver inflammation by dysregulating the Hippo signaling pathway in the liver. Alcoholic liver disease (ALD) is a major cause of morbidity and mortality worldwide, and it includes a broad spectrum of disorders, ranging from simple steatosis to severe forms of liver injury such as alcoholic hepatitis, cirrhosis, liver failure and hepatocellular carcinoma. Understanding the previous unknown regulation of Hippo signaling in ALD mouse models will provide new research directions and therapeutic opportunities.